Data Exploration and Visualization Tools for HuBMAP and a Human Reference Atlas

To enable the Human BioMolecular Atlas Program (HuBMAP) Consortium production phase, we
will develop several new and improved spatial single cell and bioimaging data visualization
features. These include Vitessce support for large volume 3D data combined with 2D
maps, spatial queries in 2D maps via HuBMAP Data Portal UI and Vitessce, user workspaces
with support for co-analysis of community and HuBMAP data, “datahubs” for external data that
can be displayed in context of Human Reference Atlas and HuBMAP data, new file formats for
3D spatial data, deployment of generalized “cell x gene” matrix format across HuBMAP Data
Portal, ability to store and share analyses of data conducted with analysis workspaces,
integration of Vitessce with Common Coordinate Framework navigation tools, UI enhancements
to scale to growing body of HuBMAP data (both in terms of volume and richness of the data and
analysis results), seamless integration between evolving Human Reference Atlas UI and Data
Portal UI. Furthermore, we will research solutions for (1) Seamless navigation through HuBMAP
and integrated community data through visual interfaces that combine data portal UI, human
reference atlas UI, and interactive visualization tools, e.g., Vitessce. (2) Extension of Vitessce
to support interpretation of functional single-cell and tissue data through network and pathway
visualizations that support 2D and 3D spatial information. (3) Rollout of “data hubs”, i.e., formats
and annotation standards for spatial single-cell and tissue data that can be viewed in the context
of the Human Reference Atlas (similar to “track hubs” for genome browsers). (4) UI-based
analysis workspaces to assemble execution pipelines for data processing and visualization.

Public health relevance
Public Health Relevance Statement: Efficient access to spatial single cell and bioimaging data generated by consortia such as the Human BioMolecular Atlas Program (HuBMAP) through data portals and visualizations tools that are designed based on comprehensive use case and persona analysis enable participation by a large audience of users across all fields of biology and medicine. We will deliver modern, web-based tools to provide such access and integrate our methods and tools with those of other key contributors to maximize the scientific impact of the HuBMAP Consortium.